MOLECULAR ANALYSIS OF THE PITUITARY GHRH RECEPTOR

DESCRIPTION: (Adapted from the applicant's abstract) Hormones from the hypothalamus mediate interactions between the nervous and endocrine systems by controlling the activity of specific target cells in the anterior pituitary gland. The hypothalamic peptide growth hormone-releasing hormone (GHRH) acts on pituitary somatotroph cells to stimulate their proliferation during development and to regulate their ability to produce and secrete growth hormone (GH). Specific Aim 1 of this proposal will investigate the transcriptional regulatory factors and external hormonal influences involved in somatotroph differentiation, using the GHRH receptor as an important marker of the somatotroph cell lineage. Aim 1A will examine somatotroph cell-specific expression of the GHRH receptor gene, using cell transfection and transgenic animal approaches to identify important gene regulatory elements and transcriptional regulatory factors. Aim 1B will extend these studies by establishing how steroid hormones modulate expression of the GHRH receptor gene during development, leading to alterations in pituitary responsiveness to GHRH and to sexually dimorphic patterns of GH secretion. Specific Aim 2 of this proposal will investigate the signal transduction pathways leading to somatotroph cell proliferation and GH synthesis and secretion, using signaling through the GHRH receptor as a model. Aim 2A will examine GHRH-stimulated MAP kinase activation and cell proliferation in a GHRH-responsive pituitary somatotroph cell line. Aim 2B will extend these studies by defining interactions between the signaling pathways activated by GHRH and those activated by synthetic GH secretagogues, leading to the synergistic actions of these hormonal factors on pituitary GH secretion. The investigator expects that these studies of the regulation and activity of the GHRH receptor will provide insights into pituitary somatotroph cell function and thus an understanding of diseases of the GH axis that are relevant to human health.